A Formative Evaluation of a Trial for OEF/OIF Veterans with Chronic Pain

A Formative Evaluation of a Trial for OEF/OIF Veterans with Chronic Pain Abstract Background: Pain is a pervasive health problem among veterans, including OEF/OIF (Operation Enduring Freedom/Operation Iraqi Freedom) veterans, but there is a paucity of research on how to best treat pain in this group of veterans. Currently underway is the VA RR&D funded ESCAPE (Evaluation of Stepped Care for Chronic Pain) intervention, a stepped- care intervention for OEF/OIF veterans with chronic pain. This trial will provide quantitative data to assess the overall effectiveness of a complex pain intervention. However, ESCAPE was not designed to determine which components of the ESCAPE trial are effective (or ineffective) for pain management and why patients believe them to be so. Objective: This pilot study will be a formative evaluation ESCAPE. While ESCAPE was designed to assess the overall effectiveness of a complex, stepped care pain intervention, it was not designed to determine 1) which individual components of the trial (i.e., optimization of analgesics, self-management, cognitive behavioral therapy, patient-provider communication) are perceived by veterans to be most or least helpful;or 2) how veterans who demonstrate a clinically meaningful response to the intervention may differ from those who did not respond. These detailed data of veterans'own perceptions and experiences of ESCAPE, including what worked and did not work for them, are critical for the design of a subsequent intervention for OEF/OIF veterans with chronic pain that builds upon the strengths of ESCAPE and improves upon its deficiencies as identified by veterans. Methods: We will conduct in-depth interviews with 30 veterans who have completed the ESCAPE intervention. Sampling will be purposeful in order to include veterans from 3 specific groups of interest: 1) veterans who demonstrated a clinically meaningful response to the trial (defined as a 30% reduction in pain symptoms);2) veterans who did not respond to the trial; and 3) veterans who adhered to less than 50% of the trial. Interview questions will relate to veterans'experiences with the individual components of the intervention, their overall perceptions of the interventions, strengths of the trial, suggestions for improvement, and veterans'views of the communication they experienced with their care providers during the trial. After conducting an emergent thematic analysis, we will then compare veterans'perceptions of the intervention to determine if these perceptions differed based upon their clinical response or adherence to the intervention. The data from this formative evaluation, coupled with ESCAPE's quantitative data, will allow us to employ elements of ESCAPE that veterans found helpful, reevaluate and modify elements that veterans found unhelpful, and work to maximize patient retention and adherence in the next trial. Data from this formative evaluation are crucial to improve care for OEF/OIF veterans who continue to come home with debilitating and painful injuries.

Public health relevance
Impact. This pilot project and the future intervention study it will inform directly address VA's priorities regarding management of chronic pain, and the findings from this program of research will be vitally important as additional OEF/OIF veterans return home with debilitating pain requiring long term management. In addition to Congress declaring the period of 2001 to 2010 as the "Decade of Pain Control and Research," VA has pioneered innovative organizational efforts, such as "Pain as the 5th Vital Sign" initiative and the VHA National Pain Management Strategy to effectively address pain among veterans. However, chronic pain is still a pervasive problem in the VA. Further, OEF/OIF veterans are returning home with injuries from explosive devices, motor vehicle accidents, and other battlefield trauma. As a result, it is imperative to identify the best combination of treatments to maximize favorable outcomes for OEF/OIF veterans. This pilot study directly addresses this need.